Investigating the role of CELSRs, a family of adhesion-type GPCRs, in hippocampal neural circuit assembly

Summary
Foundational to any actualized behavior are the processes of synapse formation and synaptic
specificity that facilitates neural circuit wiring. These concerted efforts begin embryonically and
are continuously refined throughout life. Therefore, any disruption in this system of actions can
result in neurological disorders, which remain largely untreated due to the lack of knowledge of
essential molecules and how they can respond to extracellular stimuli to promote intracellular
bidirectional synaptic signaling. Adhesion class GPCRs have emerged as candidates for this
role as they have been shown to be capable of extracellular adhesion and intracellular GPCR-
mediated signal transduction. Latrophilin 2 and 3 are adhesion GPCRs that can mediate
synapse formation as well as precise wiring of the hippocampus by activating a classical GPCR-
signaling pathway. Interestingly, the only other adhesion GPCR, along with Latrophilin, to be
conserved from vertebrates to invertebrates, is the Cadherin EGF Laminin-g Seven-pass G-type
Receptor (CELSR) 1-3. Invertebrate models of CELSRs have been shown to mediate planar
cell polarity, neuronal migration, dendritic growth, and axon guidance in the brain. However,
CELSRs in this capacity have been critically understudied in the mammalian brain. Our lab has
found that CELSRs are expressed in pyramidal cells of the hippocampus. CELSR2 and
CELSR3 are the highest expressed and each possess unique cleavage properties.
Consequently, my project strives to elucidate the role of CELSR2 and CELSR3 at mammalian
hippocampal synapses by employing the use of novel epitope-tagged floxed conditional
knockout mice. Aim #1 will characterize CELSR2 and CELSR3 function in knockout and control
mice by employing electrophysiological assays and staining to assess synaptic
neurotransmission and localization. Aim #2 will uncover the signaling mechanisms in which
CELSR2 and CELSR3 mediate function via rescue electrophysiology experiments using
previously found mutants of CELSR2 that prevent GαS coupling and CELSR3 seizure mutations
located in the transmembrane region.

Public health relevance
Narrative Synapses have the innate capability of assembling into neural circuits that mediate nearly all behavior, yet their mechanism of action remains unclear. Emerging evidence has shown adhesion class GPCRs to play a key role in these processes, and their mutations have been implicated in neurological disorders such as autism and ADHD. Due to the cadherin adhesion GPCR, CELSR, being shown to play a role in invertebrate neuronal migration, dendritic growth, and axon guidance this project employs the use of cKO CELSR mice to uncover its unknown role in these fundamental processes and its relation to neurological dysfunction in mammals.